Integrated Epidemiologic Study of Ultra-processed Foods and Colorectal Cancer Survival

PROJECT SUMMARY/ABSTRACT
Colorectal cancer (CRC) remains a leading cause of cancer deaths in the US and is one of the cancers most
strongly associated with a suboptimal diet. Within various dietary components, ultra-processed foods (UPFs) are
emerging as an increasingly important risk factor for CRC. UPFs make up nearly 60% of Americans' daily
calories. A high UPF intake may increase CRC risk or worsen its prognosis through altered metabolites that may
impact glycemic or inflammatory responses, or tumor microenvironment, resulting in cancer progression. Food
processing may also introduce carcinogens and certain UPF components can contribute to somatic mutations.
Besides, a high UPF intake is associated with excess intake of calories, leading to adiposity, an established risk
factor for CRC. Thus, UPFs could be an important dietary risk factor for CRC progression and yet the UPF-CRC
survival has not been adequately studied. While evidence suggests that CRC progression is associated with
metabolites modulated by diet, the metabolomic profiles associated with UPFs remain to be characterized.
Constituents of UPFs such as red or processed meats have been related to alkylating DNA damage and
increased CRC mortality, yet the role of UPFs remains unclear. These unknowns highlight the critical need to
comprehend the association between UPFs and CRC survival and the molecular determinants of this relationship
for improving long-term CRC survivorship. Well-established large prospective cohort studies are crucial to
offering rigorous data to elucidate the diet-disease association and infer causality. Advances in high-throughput
metabolomic profiling and whole-exome sequencing (WES) show great promise to identify sensitive biomarkers
that could better predict the diet-disease relationships. The overarching research goal of this F99/K00 proposal
is to investigate the role of UPFs in CRC survival by integrating high throughput -omics and detailed dietary data
collected among men and women from large cohorts. The F99 phase will focus on investigating the association
between UPF intake and deaths due to CRC and all causes among CRC survivors (Aim 1); the K00 phase will
shift the focus to investigating the molecular correlates of UPF-CRC survival relationship by integrating
metabolomics profiling and tumor WES data and exploring the feasibility of a pilot intervention to reduce UPF
intake among CRC patients (Aim 2). The research findings will inform dietary recommendations for CRC
survivors, accelerate the discovery of novel biomarkers to pave the way for precision nutrition in oncology care,
and provide new insights into nutrition interventions for improving the long-term survivorship of CRC. Under the
mentorship of sponsors at Tufts Friedman School of Nutrition Science and Policy and Harvard T.H. Chan School
of Public Health, the candidate will acquire rigorous research training and professional and career development
skills for transition to an independent research career focus on studying the role of nutrition in cancer control and
translate evidence into effective nutrition interventions and clinical practices to improve cancer survivorship.

Public health relevance
PROJECT NARRATIVE Ultra-processed foods (UPFs) are emerging as an important risk factor for colorectal cancer (CRC) and may negatively affect survival outcomes. The proposed research will study how UPFs and the molecular correlates can impact CRC survival, leveraging large cohorts and integrating metabolomic profiling and whole-exome sequencing data. This timely, innovative research will inform dietary recommendations for CRC patients, contribute to the discovery of novel, actionable targets with the potential use in precision nutrition and oncology care, and provide new insights into the design of nutrition interventions to improve long-term CRC survivorship.